Understanding the mechanisms that regulate cytoplasmic capping and defining its contributions to post-transcriptional gene regulation

R35_Project Summary/Abstract
The N7-methylguanosine (m7G) cap is a unique molecular identifier that is a focal point for post-transcriptional
gene regulatory pathways. The m7G cap serves as both a roadblock to enzymes that would degrade the mRNA
and a landing pad for cap binding proteins that coordinate the pre-mRNA processing, nuclear export, and
translation initiation of most mRNAs. Until recently, capping was thought to be exclusively nuclear, and
decapping was thought to irreversibly destine the RNA to degradation. Simply stated, cytoplasmic capping is
the process by which an m7G cap is returned to an uncapped mRNA in the cytoplasm. Cytoplasmic capping
requires NCK1 to coordinate the sequential actions of an unknown kinase, the capping enzyme, and an RNA
methyltransferase, which phosphorylate and cap the targeted mRNA and methylate the newly-added cap
respectively. Although we have learned much about the biochemistry of cytoplasmic capping, many fundamental
questions remain unanswered. The hypotheses driving this proposal are that: (1) Specific RNA sequence
elements (or modifications) recruit and/or trigger cytoplasmic capping activity and that (2) the cytoplasmic
capping of 5’-truncated mRNAs serves as a new tier of post-transcriptional gene regulation. This study will seek
answers to three key questions. First, a combination of data mining and new sequencing experiments will
uncover the sequences that target an mRNA to the cytoplasmic capping machinery. A bioinformatics approach
integrating published data sets marking cap positions and transcription start sites (TSS) will identify non-TSS-
associated caps. Oxford Nanopore direct RNA sequencing will then compare RNA harvested from cells +/-
dominant negative cytoplasmic capping components to map full-length mRNA sequences. The synthesis of
these studies should ascertain the 5’ ends, the alternative splicing patterns, and polyadenylation site choices of
cytoplasmically capped mRNAs. Second, CRISPR knockouts of mRNA decapping enzymes (Dcp2, DcpS, etc)
and candidate endonucleases will identify the cellular mechanism(s) that generate uncapped ends for the
cytoplasmic capping machinery. These knockouts will be paired with focused and transcriptome-wide methods
to validate changes in cytoplasmic capping. Third, a combination of in vivo RNA labeling experiments and
ribosome profiling will establish how cytoplasmic capping surveys mRNAs during the onset of the stress
response. The generation, cytoplasmic capping, and translation of 5’-truncated mRNAs into N-terminally-
shortened proteins would effectively be a new tier of post-transcriptional gene regulation with far-reaching
impacts on the function(s) of the N-terminally truncated proteins. To summarize, this work will (1) identify and
validate the sequences that regulate cytoplasmic capping (2) determine the mechanism(s) by which RNA
substrates are generated for cytoplasmic capping, and (3) understand the in vivo function(s) of cytoplasmic
capping during the onset of acute stress responses.

Public health relevance
Project Narrative Several tiers of regulation ensure that genes are properly expressed in cells. Cap structures added to the beginnings of messenger RNAs (mRNAs) are critical for their regulation and represent one such mechanism. Cytoplasmic capping is an understudied process that returns a cap onto uncapped mRNAs and is likely another layer of the cell’s regulatory framework. This work’s goals are to determine how targets are generated for the cytoplasmic capping machinery, how that machinery recognizes mRNAs and the effects of cytoplasmic capping on cellular proteins in normal and stressed conditions.